Adipogenesis and Insulin Resistance

For nearly the past decade we have been studying the relationship between insulin resistance and adipocyte size in a number of settings. The key ideas we have distilled from these investigations include: 1. Adipose cells vary widely in size from about 20 microns in diameter to well over 100 microns, befitting their unique role as cells that can expand and contract to take up and release lipid as needed. 2. The distributions are not typical unimodal Gaussian distributions but typically have a Gaussian-like peak of large cells and an exponential-like tail of small cells. We have interpreted the Gaussian peak as representing mature adipocytes and the tail as newer cells in the process of growing as they take up lipid. Dynamical models by others in the lab (see reports by Vipul Periwal, LBM) have confirmed that a hypothesized growth process incorporating newly recruited cells emerging with diameter around 20 microns and growing according to a size-dependent growth law naturally generates such distributions. A distinct nadir between the left tail and the right peak is found if cells are assume to grow slowly until they reach a threshold diameter of, say, 30 - 60 microns and then grow rapidly. In some individuals, both human and rodent, an additional peak of cells with intermediate diameter can be observed, which may even move to the right with time, suggesting a bolus of cells recruited close together in time that grows and joins the peak of mature cells. 3. We have correlated the characteristics of the size distributions, chiefly the fraction of small cells and the typical size of the large cells, with insulin resistance or sensitivity in a variety of study populations. Our initial study, in collaboration with the McLaughlin lab at Stanford University, examined moderately obese subjects (BMI near 30 kg/m2) who were insulin sensitive (IS) or insulin resistant (IR) and found that the insulin resistant group had an increased proportion of small cells. This was interpreted as a signature of impaired adipocyte development, which could result in impaired lipid storage capacity and lead to spillover of lipid to other organs poorly equipped to handle the fat load. Such spillover, or ectopic fat has been proposed to cause insulin resistance in muscle and liver and impaired insulin secretion in the pancreas. The study noted a trend toward larger large cells among the IR subjects, but this did not reach statistical significance. One would expect larger large cells given a smaller proportion of large cells if BMI and total fat mass are the same between the groups, as they were by design. A follow-up study in progress with a larger group of subjects and a broader range of BMI has confirmed the increased proportion of small cells as well as larger large cells. The latter feature has been reported by many other studies, but the role of the proportion of small cells has been less well appreciated. Ref. # 1 of this report (collaboration with the Smith lab, Gothenburg) examined this question for a group of younger and leaner subjects who were first degree relatives of individuals with type 2 diabetes. In this group, which may differ genetically as well as environmentally and developmentally, insulin resistance correlated with large size of the large cells but not with the proportion of large cells. It may be that the large cells of this less obese cohort, which were smaller on average than those of the more obese cohort, have greater ability to expand and hence there is less need to recruit new small cells. A considerable body of evidence from other studies supports the notion that large cells are intrinsically less efficient at storing lipid than small cells (again, see report of Periwal, LBM, for a theoretical view of this). 4. We have also examined non-diabetic IR subjects who were treated with the insulin-sensitizeer pioglitazone (McLaughlin lab; see 2009 report). The drug improved the subjects' insulin sensitivity and increased both the proportion of small cells and, by estimate, the number of large cells, suggesting that adipogenesis was enhanced. This study shows that the proportion of small cells by itself is ambiguous; the contribution of the small cells to the metabolic state of the individual depends on whether those cells are arrested in development or available to expand and take up lipid. Further study will be required to assess whether the cells in pioglitazone-treated subjects differ in their capacity to expand from small cells in untreated IR subjects. This currently stands as a prediction of the model. A timecourse study with the Smith lab has shown that administration of insulin-sensitizing drugs, such as pioglitazone or rosiglitazone, leads to both recruitment of new cells, which increases the proportion of small cells, and expansion of existing large cells (work in progress). In summary, in all these cases the distribution of adipose cell sizes is related to metabolic status, but the particular response is dependent on the metabolic status and history of the subject. The results above, taken together, along with work in other sections of LBM, lead to the overall conclusion that large cell size is a primary risk factor for insulin resistance, along with an excess of small cells. We hypothesize that in untreated IR subjects the surplus of small cells reflects impaired differentiation. Indeed, the two properties may be related, as a defect in potential to recruit and enlarge new adipocytes may be compensated by enlargement of existing adipocytes beyond their healthy operating range.